IDeA National Resource for Quantitative Proteomics

Abstract
Since 2020, the IDeA National Resource for Quantitative Proteomics has operated as a NIGMS R24 National
Resource in support of NIH-funded investigators, and other academic researchers and qualified scientists across
the United States, by providing the most cost-effective access to state-of-the-art proteomics platforms and
supporting a substantial nation-wide biomedical research community with unique education, outreach, and
training opportunities. In this renewal, we seek to build on the high level of success during the current funding
cycle by expanding access to and opportunities in service, education, outreach, and training for quantitative
proteomics to a growing nation-wide userbase. Our intent is to provide broad access to investigators without
regard to the specific biomedical focus of their research, while not duplicating or replacing resources supported
by NIH or host institutions. With robust institutional support, we will use best-in-class practices to enable user
access to the next generation of liquid chromatography-coupled mass spectrometry systems and skilled staff for
data collection and analysis. We will make our capabilities and abilities broadly known to the nation-wide
biomedical research community through advertisement, education, and outreach. The goals of the IDeA National
Resource for Quantitative Proteomics are to provide unmatched and most cost-effective access to state-of-the-
art quantitative proteomics platforms and education, outreach, and training opportunities that will increase the
capacity of NIH-funded investigators, and others in academic laboratories across the United States, to perform
cutting-edge biomedical research. By pursuing our goals, we will support the biomedical research mission of NIH
for both fundamental and translational research focused on human diseases including cancer. We will pursue
the following Specific Aims to accomplish our goals: (1) Provide state-of-the-art proteomics services to a nation-
wide userbase, (2) Provide educational opportunities for quantitative proteomics to a nation-wide userbase, and
(3) Provide outreach and training for quantitative proteomics to a nation-wide userbase.

Public health relevance
Narrative The goals of the IDeA National Resource for Quantitative Proteomics are to provide unmatched and most cost- effective access to state-of-the-art quantitative proteomics platforms and education, outreach, and training opportunities that will increase the capacity of NIH-funded investigators, and others in academic laboratories across the United States, to perform cutting-edge biomedical research. The IDeA National Resource for Quantitative Proteomics serves the biomedical research mission of NIH for both fundamental and translational research focused on human diseases including cancer.